A Low-Cost Wearable Connected Health Device for Monitoring Environmental Pollution Triggers of Asthma in Communities with Health Disparities

Project Abstract
Asthma affects 25 million Americans, and chronic obstructive pulmonary disease (COPD) affects 16 million,
together costing 130 billion USD annually to the US healthcare system. Asthma is more prevalent in African
American population (10.6%) than white population (7.7%). Poverty level has an impact as well, with twice as
much asthma incidence in people below 100% of the poverty threshold as compared to people above 450% of
the threshold. Racial-ethnic and socioeconomic health disparities in the US due to air pollution exposure are well
documented and have persisted despite overall decreases in ozone and particulate matter pollution. This
disproportionate exposure reflects generations of discriminatory practices including racially-segregated
residential policies that result in communities of color being more frequently located near major sources of air
pollution, both industrial and transportation-related. The proposed research project seeks to address health
disparities related to air pollution by enabling self-monitoring of environmental triggers of asthma and other
respiratory diseases, so that the patients are empowered for self-management of their disease. This study will
develop and test a wearable sensor array with a small form-factor for monitoring personal exposure to several
important air pollutants, and then pilot this device in a small panel of African-American adults with physiciandiagnosed asthma. The device will be sensitive to a variety of primary and secondary pollutants from both motorvehicle traffic and industrial emissions. It will employ metal oxide semiconductor sensors to measure ozone,
nitrogen dioxide, and volatile organic compounds as well as relative humidity and ambient temperature. The
device will be able to connect to Bluetooth-enabled smartphones for data logging and display purposes, yet it
will be small enough to be worn on the wrist. We will validate the utility of this device for improving health by
recruiting 20 African-American adults who live in the Atlanta area and have been diagnosed with asthma. These
participants will use the device to monitor their air pollution exposure for one month. During this month, they will
also measure their lung function twice per day using a small commercially-available spirometer that we will
provide them. We will develop a smartphone application that will clearly display air quality data in an intuitive
color-coded display. The app will also include lung function data from spirometry in a percent-predicted score
relative to expected values based on age, height, sex and race. The overall goal of this project is to demonstrate
the feasibility of a wearable device to assist in the identification of air pollution-related asthma triggers and to
empower asthma patients to improve their health by reducing exposure.

Public health relevance
Project Narrative This study will improve health in racial/ethnic and socioeconomic minorities with health disparities by enabling them to identify air pollution triggers of asthma in personal microenvironments. We will develop and test a device that can be worn on the wrist and measures personal exposure to air pollution in both indoor and outdoor microenvironments. Study participants will also monitor their lung function, and we will develop a smartphone application that displays both air pollution and lung function, so that asthma and COPD patients can proactively monitor environmental triggers in real-time and benefit from self-management of their disease.